NIMHD Space Activation

For the FY 25 year we have reduced our dry lab space due to staff departure. We relinquished office space in Two White Flint, 10the Floor, Rockville, MD, which currently houses 3 investigators and their research teams, and a staff scientist, a training director, and an operations coordinator. We also relinquished office space in Building 3, 5th Floor, Bethesda, MD. Two investigators and their research teams, the Scientific Director, a nurse practitioner, and an operations coordinator are currently housed in Building 3. Staff and fellows from an additional research team are in the office space in Building 29B, 2nd Floor, Bethesda, MD. An additional research team is housed in Building 10, B1 Floor, Bethesda, MD.

For the FY 25 year we have maintained our wet lab space. This include Building 29B Rooms 2E18, 2E20, and a portion of the shared space in 2N02 assigned to NIMHD DIR for freezers.

We continue to work with ORF on the renovation of a clinical space in Building 10 CRC assigned to us in FY23 to support future clinical research in supporting the NIH and NIMHD mission.